Regulatory Support Services

The Office of Clinical Research Policy and Regulatory Operations (OCRPRO) supported the conduct of 254 material and active clinical trials in FY21 from 24 NIAID laboratories and other clinical research projects by providing an array of services to ensure that FDA and other DHHS regulations were fulfilled including; (1) appropriate management of investigational new drug sponsor responsibilities; (2) institutional review board functions; (3) data and safety board management; (4) clinical safety reporting, and; (5) clinical trial monitoring for study compliance. Additionally, OCRPRO manages over 100 Investigational New Drugs, Investigational Devices, and Master Files for studies conducted at the NIH Clinical Center, at academic medical centers throughout the US, and in 17 countries. These activities constitute a collective safety system to protect research participants and enhance the integrity of study conduct for NIAID sponsored research. OCRPRO staff continued to provide a comprehensive protocol development program to assist intramural clinical researchers in the launching of new studies. Moreover, the policy staff of OCRPRO continues to provide consultation on requirements and evaluation for an NIAID-wide quality management system. While many of these activities took place within the context of the traditional NIAID intramural program conducted at the NIH Clinical Center, several of the actions assisted in the accomplishment of larger NIAID actions conducted through NIAID ICERs (International Centers for Excellence in Research), disease-specific networks (Influenza Research Collaboration), and programmatic networks such as the DOD Uniformed Services University Infectious Disease Clinical Research Program (IDCRP) and the Indonesia Research Partnership on Infectious Diseases (INA-RESPOND). Additionally, OCRPRO staff remained involved in supporting the Partnership for Research on Ebola Virus in Liberia (PREVAIL) as well as extension of follow-up for multi-sponsor/multi-partner PREVAC study. All OCRPRO activities were conducted with a focus on coordination of activities by the respective regulatory functions in an effort to promote the timely and effective operation of the research enterprise to include the intramural research programs in HIV, biological defense, and emerging infectious diseases.